Pulmonary toxicological evaluation and chemical interactions of menthol, mint, and tobacco flavored e-cigarette products

PROJECT SUMMARY (See instructions):
Menthol, cooling/ice, and tobacco flavors are among the most abundant for Electronic Nicotine Delivery
Systems (ENDS) or electronic cigarettes. These flavors are not regulated due to the potential public health
benefit cessation of combustible tobacco use. However, the toxicological effects of vaping these products
are not entirely understood. Further, increased use of cooling/ice/menthol-like products is correlated with
higher e-cig consumption due to their cooling and antitussive properties. However, the modified risk and
toxicity of these products are poorly understood. The K99 /R00 proposal aimed at identifying the chemical
agents (flavoring chemicals) that cause lung toxicity using cell culture and mouse models. As the K99
phase provided biologically significant data from acute exposures, we will continue the same aims as below
with a modified R00 plan mainly focusing on sub-chronic (in vitro) and chronic (in vivo) exposures
mentioned in Aims 2 and 3. The R00 phase will focus on validating the toxicants identified in the aerosols
and relating them to the biological response and biomarkers. Moreover, these findings will be validating
during prolonged exposures to flavored ENDS and chemical agents. This study hypothesizes that
menthol/cooling flavors and tobacco flavors contain harmful chemicals that induce adverse cellular and
biological responses and chemically interact upon aerosolization, causing augmented toxicity with preexisting respiratory conditions. Aim 1: Identify the chemistry of menthol, menthol-like (cooling), and tobacco
flavors, including flavoring chemicals and secondary products formed upon aerosolization. Aim 2:
Determine in vitro and in vivo toxicity and health effects of menthol, menthol-like (cooling), and tobaccoflavored ENDS in EpiAirway 3D tissues and mice (C57BL/6J and BALB/C) under normal and pre-existing
respiratory conditions. Aim 3: Determine in vitro and in vivo toxicity and health effects of menthol, menthollike (cooling), and tobacco flavoring chemicals in EpiAirway 3D tissues and mice (C57BL/6J and BALB/C)
under normal and pre-existing respiratory conditions. In R00 phase, effects in lung after sub chronic
and chronic exposure to CS and then switching over to ENDS (menthol, cooling, and tobacco) will
also be determined, allowing to assess the benefit or the modified toxicity of switching from CS to ENDS.
This will further be studied in normal, asthma, and COPD, 3D tissues (sub chronic) and mice with the same
phenotypes. Thus, Dr. Muthumalage, in his R00 proposes to perform a comparative toxicity, and
biomarkers of disease under normal and pre-existing respiratory disease conditions providing information
necessary for regulation of harmful constituents in these products.

Public health relevance
RELEVANCE (See instructions): Tobacco and mentholated e-cigarette flavors are widely available and using these products are considered safer than traditional cigarette use. Toxicity and health effects of these flavors and what agents cause those health effects are not known. This R00 proposes to perform short term and long-term effects of exposure to menthol, mint, and tobacco flavored e-cigarettes on lungs and how the exposure affect pre-existing lung conditions.